Characterization of the function and regulation of long noncoding RNA Interferon gamma- anti-sense 1

Project Summary/Abstract The idea that long noncoding RNAs (lncRNA) play an important role in regulating gene expression is a quickly growing concept. The lncRNA IFNG-AS1 is found in a multi-cytokine locus which includes IFNG and IL22. IFNG-AS1 has been shown to play an important role for positively regulating the expression of IFNγ expression in both human and mice. Current research concerning the role for Ifng-as1 suggests its role as a positive regulator of Ifnγ, but preliminary data outlined in this grant shows examples of discordant expression of Ifng-as1 and Ifng. This finding suggests an alternative regulation of this lncRNA. The goal of this proposal is to understand the function and regulation of Ifng-as1 under different cellular settings. In Aim 1 we have proposed to define the relationship between Ifng-as1 and the genome under different cellular settings and different cellular states using HiChIRP (i.e. CD4+ T cells and plasma cells). We will also determine what factors are differentially bound to Ifng-as1 through ATAC-seq and ChIP-seq. We will additionally describe a metabolic role for the regulation of Ifng-as1 in particular glycolysis and glutaminolysis through the use of metabolic inhibitors and nutrient supplementation. In Aim 2 we will define proteins bound to Ifng-as1 through RAP-MS and defined the function of Ifng-as1 by deleting Ifng-as1 and its regulatory elements by using CRISPR/Cas9 technology. Finally, we will seek to determine a role for Ifng-as1 in an in vivo setting for ILC3 differentiation and memory development. The findings from this proposed study will provide novel mechanistic information concerning the regulation of Ifng-as1 and Ifnγ providing novel targets for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Long noncoding RNAs (lncRNAs) play an important role in gene regulation across multiple cell types. The lncRNA Ifng-As1 is positioned within a multi-cytokine locus shown to be a positive regulator of Ifnγ expression and has been shown to play a role in genome architecture however the function and regulation remains poorly understood. The goal of this proposal is to acquire a better understanding of the regulation and function of Ifng-As1 through the use of multiple next-generation sequencing techniques.